ANTIVIRAL DRUGS TO CURE CHRONIC HEPATITIS B VIRUS INFECTION

To support a Phase II proposal to develop a new hepatitis B virus (HBV) cure drug. The Phase II proposal seeks to expand on the development of the lead compound supported under a Phase I study.